Rectifying splicing mutations in blood disorders by gene editing

Inherited blood disorders are especially favorable targets for therapeutic genome editing in
that ex vivo modification of patient hematopoietic stem cells (HSCs) followed by autologous
transplantation can result in lifelong recovery of normal blood cell production. Recently we
developed an improved version of SpCas9 (3xNLS-SpCas9) and an efficient electroporation protocol
for genome editing of CD34+ hematopoietic stem and progenitor cells (HSPCs) using SpCas9
ribonucleoprotein (RNP) that leads to highly efficient on-target gene modification, preservation of
HSC function and undetectable off-target editing.
In principle , homologous recombination (HR) or base editing could be harnessed for the precise
correction of disease-associated mutations. However, the requirement for co-delivery of donor
template sequence, the cell cycle dependence of HR-based gene repair, and the competing
nonhomologous end­ joining/microhomology mediated end joining mutagenic repair pathways
complicate achieving efficient HR in HSCs. Base editing Is currently limited in its targeting range
with uncertainty about potential genotoxicity and HSC efficiency. Nuclease-induced predictable
end-joining repair (with indels) is a highly efficient means of gene modification, and could
itself be therapeutic depending on the allelic outcome. This strategy may be particularly
effective for noncoding mutations that impact regulatory elements, such as those that dictate the
pattern of mRNA splicing. We hypothesize that genome editing, by directing efficient non-templated
end-joining DNA repair in HSCs, could restore gene expression and provide durable therapy for
inherited blood disorders associated with splicing mutations.
Two of the most common mutations associated with transfusion-dependent β-thalassemia are HBB IVS1-
11OG>A and IVS2-654C> T which introduce intronic aberrant splice acceptor and donor sites
respectively.
Using SpCas9 and LbCas12a RNPs, we have successfully disrupted these inappropriate regulatory
elements in HSPCs from multiple patient donors. The erythrocytes differentiated in vitro from
these nuclease-treated cells display robust increase in normally spliced HBB mRNA and restored
adult hemoglobin (HbA) expression, suggesting that this is a potent strategy for therapeutic
development. In Aims 1 & 2 we will develop Cas9 and Cas12a editing reagents for these splicing
mutations through nuclease optimization, unbiased genome-wide off-target analysis, and assessment
of HSC editing rates through xenoengraftment of edited β-thalassemia patient HSPCs. In Aim 3, we
will develop efficient strategies for the non-templated gene editing repair of splice junction
disrupting mutations for the IVS2+2T>C mutation in SBOS commonly associated with Shwachman­
Diamond syndrome. The successful completion of these studies w/1 define editing approaches for the
efficient HSC repair of a range of pathogenic splicing mutations that impact hematopoiesis and enable the
development of targeted reagents based on existing nuclease platforms for definitive gene therapy.

Public health relevance
Beta-thalassemia and Shwachman-Diamond syndrome are severe blood disorders caused by abnormal genes that cannot be properly processed. We propose to develop innovative gene editing methods that can repair the abnormal genes that cause these diseases to restore their normal processing. These methods could then be used to fix the genes of blood stem cells of patients outside the body, and then the modified cells returned to the patient to cure the blood system of disease, like a bone marrow transplant but using the cells of the patient instead of from another person.